Dissecting the roles of ubiquitin in translation control

Project Summary
This research program will investigate new mechanisms by which eukaryotic cells regulate gene expression at
the protein level during exposure to stress. Failure to reprogram protein expression and inadequate management
of unneeded and damaged proteins are the underlying causes of a variety of neurodegenerative diseases, tumor
progression, and the process of aging. Understanding and modulating stress defense pathways, such as
translation reprogramming, would provide new tools to promote healthier lives and fight diseases. Therefore,
this proposal will focus on deciphering new molecular mechanisms by which a series of ubiquitin-
mediated processes regulate translation through the control of ribosome structure and function during
stress. My laboratory discovered in budding yeast that ribosomes are heavily modified by K63-linked
polyubiquitin chains in response to oxidative stress, as part of a new pathway named Redox control of Translation
by Ubiquitin (RTU). In the last funding cycle, we identified key enzymes involved in ubiquitination and
deubiquitination of ribosomes in the RTU (Rad6, Bre1, and Ubp2) and their mechanisms of regulation in the
presence of reactive oxygen species (ROS). We further showed that ubiquitination of ribosomes arrests them in
a sequence-specific manner at the elongation stage of translation. Finally, we developed new proteomics tools
to characterize the dynamics of ribosome ubiquitination during stress progression with amino acid resolution.
Inactivation of the RTU leads to translation dysregulation and sensitivity to stress, but the mechanisms controlling
ribosome pausing in the RTU remain largely elusive. This proposal will explore four key questions in our research
program: 1) How does unique sites of ubiquitination regulate ribosome fate and function during oxidative stress
and how do they differ from other quality control systems? 2) Why and how do ribosomes pause at selective
mRNA motifs in the RTU? 3) What is the molecular composition and the nature of cofactors regulating redox
ribosome pausing? 4) How does ubiquitin regulate translation in human cells during oxidative stress? My
research uses a combination of molecular, cellular, biochemical, computational, and high-throughput
approaches in proteomics and genomics, which has provided a solid and rigorous foundation for a continued
exploration of the mechanisms driving gene expression at the translational level. The overarching goal of my
research laboratory is to leverage the power of the ubiquitin proteasome system (UPS) in regulating the
proteostasis network to design new treatments and interventions for stress-related diseases.

Public health relevance
Narrative To survive the harms of environmental challenges, cells must reprogram their protein profile by building proteins important for cellular protection, while preventing the production of unnecessary ones. The goal of this research program is to decipher the rules driving the reprograming of protein production under stress, which will support cellular resistance to damage and prevent disease states.